Data Science Core

Abstract
Clinical studies of individuals with intellectual and developmental disabilities (IDDs) often involve small sample
sizes, longitudinal behavior measurement, and the integration of genetic data. These multifaceted studies
invariably require complex methods for data analysis and careful attention to study design to ensure rigor and
reproducibility. In addition, massively parallel sequencing technology and multi-modal brain imaging studies
generate a deluge of data that must be carefully analyzed to distil biological meaning. Likewise, preclinical
studies of IDDs often generate multimodal behavioral, genetic, and other molecular omics data that require
complex analytic approaches. While these technologies provide unprecedented opportunities to develop
diagnostic tools and personalized interventions for individuals with developmental disorders, most scientists lack
the expertise and resources in bioinformatics, biostatistics, computer science, and psychometrics, to make full
use of these advanced approaches. The Data Science Core (DSC) was established to make available these
critical services and resources to IDDRC investigators and other IDDRC research cores. In this application, 41
projects from 27 IDDRC investigators are proposed for core access. The DSC interacts with the large user base
of IDDRC investigators and the Preclinical (PC) and Clinical Translational (CTC) Cores to provide state-of-the-
art processing and analysis of modern biomedical data. By consolidating resources and expertise, the DSC
facilitates inter-disciplinary, collaborative IDD research, employing the methods of biostatistics, psychometrics,
bioinformatics and computational neuroscience. In providing expertise to analyze and interpret complex and high
dimensional data, this core maximizes the potential for IDDRC investigators to conduct cutting-edge research to
positively impact the quality of life of individuals with IDDs and their families. Through regular interactions with
the PC and CTC, the centralized services of the DSC provide expertise within and across preclinical and clinical
domains to promote cost-effective, high quality, translational research. Specifically, the DSC has the following
aims: Aim 1. To provide innovative and comprehensive biostatistics, psychometrics, and computational
neuroscience support to IDDRC investigators. Aim 2. To provide comprehensive bioinformatics support to
IDDRC Investigators. Aim 3. To facilitate integrative and multidisciplinary IDDRC research and training.